PATTERNS OF CARE STUDY IN RADIATION ONCOLOGY

Objective: To determine a consensus on the criteria for pre-treatment workup and treatment delivery in five disease sites for which radiation therapy has a major curative impact. Develop method to present data to the specialty.